EPFP - Sub Contracts

ABSTRACT: Expanded Pilot and Feasibility Program
The purpose of the Expanded Pilot and Feasibility Program (ePFP) of the Washington University Diabetes
Research Center (DRC) is to extend our Pilot and Feasibility Program to diabetes investigators at institutions
without NIDDK-supported Diabetes Research Centers. In this application, we propose to establish
subcontracts with the University of Kentucky, the University of Utah, and the University of Wisconsin-Madison,
three universities with outstanding research bases in diabetes. Philip Kern, Simon Fisher, and Alan Attie are
internationally recognized diabetes researchers with strong records of leadership, who will serve as
subcontract Program Directors at Kentucky, Utah, and Madison, respectively. Each subcontract will fund two
meritorious pilot grants per year at each institution, and the program will be well integrated with the successful
Pilot and Feasibility Program at Washington University. The ePFP leverages the success and experience of
the Washington University DRC to serve a wider scientific community and enhances scientific interchange
between investigators at the four institutions.